Role of opioid receptor trafficking in tolerance and dependence

Project Summary A fundamental question in addiction biology is why opiate alkaloid drugs such as morphine and heroin have a high liability for inducing tolerance and addiction while endorphins and enkephalins, the native peptide ligands for opioid receptors, do not. Following activation by agonists, opioid receptors are regulated by multiple mechanisms. Of these regulatory mechanisms, rapid endocytosis of opioid receptors is of particular interest because it is differentially regulated by peptide agonists and alkaloid drugs. Specifically, endogenous opioid peptides and certain opiate drugs such as etorphine and methadone stimulate the rapid internalization of mu opioid receptors. Morphine however, strongly activates receptor signaling but fails to stimulate the rapid internalization of mu opioid receptors. Furthermore, following endocytosis, individual receptors can be sorted differentially between recycling endosomes and lysosomes. This sorting mechanism can contribute to receptor regulation in two ways that have opposing effects on cell signaling. First, endocytosis can serve as a mechanism for receptor resensitization by delivering internalized receptors to endosomes from where they are recycled to the plasma membrane in a fully active state. Second, rapid internalization can serve as a first step toward receptor downregulation by delivering the receptors to endosomes from which they are sent to lysosomes for degradation. Hence for each receptor/ligand pair, one must evaluate both the endocytic and post-endocytic properties. We have generated mutant mu opioid receptors with altered endocytic and post- endocytic trafficking properties. Here we propose to utilize these mutant receptors to assess the molecular and behavioral effects of altered trafficking on the development of tolerance, withdrawal, and addiction.

Public health relevance
Project Narrative There is a great need to develop opioid therapeutics with a reduced liability to cause tolerance, dependence and addiction. Identifying the ideal properties of opioid drugs that would retain analgesia but reduce these side- effects has been a goal of my laboratory for more than a decade. Experiments proposed here are designed to address this question and elucidate the neural mechanisms underlying opioid abuse.